Harnessing big-data for plasticity and rehabilitation in translational SCI

Spinal cord injury and disorders (SCI/D) are substantial health concerns impacting veterans at a higher rate
than the civilian population. The total economic burden of SCI/D is estimated at $9 billion/year to $400 billion in
lifetime medical and loss-of-productivity costs. The most common clinical presentation is high cervical SCI/D
which produces a broad spectrum of issues, including loss of hand function, autonomy, sensory changes,
spasticity, pain and autonomic dysfunction, profoundly impacting quality of life. Restoring these functions is the
goal of regenerative and rehabilitative therapeutic approaches for SCI/D. The VA Gordon Mansfield Spinal
Cord Injury Consortium (VA-GMSCIC) is a VA-funded effort to develop late-stage translational therapeutics in
a nonhuman primate (NHP) model in preparation for testing emergent therapeutic approaches clinically. Prior
and current funding has focused on multifaceted data collection on each subject with 5 different centers
collaboratively collecting data, each within their specific domain of expertise (physiology, behavior, histology,
neurorehabilitation, and molecular biology). This is an ideal use of the NHP model, as maximal information is
collected about the performance of therapeutic approaches in a small number of NHPs. Data from this
important model is characterized by the classic ‘3Vs of Big Data’: high volume (large images), high variety
(multi-modal data), and high velocity (robotic rehab; physiology; neuromodulation), providing both a challenge
and opportunity for novel discoveries. Application of modern data science tools can help deliver on the promise
of translational precision medicine for SCI/D. As our prior work demonstrates, effective management of VA
NHP big data enables us to effectively harness VA-GMSCIC data to drive new discoveries. However,
integrating these NHP big data requires ongoing data-driven integration of robotic rehab, kinematics, histology,
and medical information. Extraction of meaningful discoveries requires extensive computational work. The
purpose of the proposed renewal is to build on our ongoing success in assembling a data commons for the
VA-GMSCIC by integrating new types of high-resolution data in support of safety/efficacy studies of novel
therapeutics. Our data science team is well positioned to achieve this goal. Our team has provided analytical
support for the VA-GMSCIC, helping to integrate data from UCSD, UCLA, UCI, UC Davis and UCSF for testing
SCI rehab and regenerative therapies in NHPs for over 13 years. We have supported development of different
injury models, behavioral assessments, electrophysiology, kinematic measures, and therapeutic approaches in
100+ subjects. Under our current merit award (ending Nov 2020), our team built on this historical background
to establish a functional primate data commons (PDC-SCI) infrastructure that enables rapid, structured data
sharing, data integration, and analytics support across the VA-GMSCIC sites. The project has helped the VA-
GMSCIC evolve from focused discovery projects to late-stage translational studies with highly-sophisticated,
large-scale “big-data” collection. We aim to expand our knowledge-discovery pipeline for these critical
translational SCI/D big data to support planned safety/efficacy studies. Specifically, the renewal will build on
our successes and expand the scope of our work by supporting integration of: Aim 1) translational electronic
health records (tEHR), Aim 2) advanced robotic rehabilitation data, Aim 3) neuromodulation data from brain-
machine interfaces, and Aim 4) advanced machine learning analytical pipelines for rapidly integrating
multidimensional data. The goal is to help VA-GMSCIC efficiently test important therapeutic candidates for
translation to humans while promoting modern data stewardship adhering to the federally-endorsed FAIR
(Findable, Accessible, Interoperable, and Reusable) data sharing principles. This will ensure that the existing
VA investment in data collection is leveraged to the maximal extent through digital technologies for enduring
knowledge-discovery from this valuable NHP model of SCI/D.

Public health relevance
Spinal cord injury and disorders (SCI/D) are a substantial health concern impacting about 273,000 Americans and 45,000 veterans. Restoring lost function is the goal of regenerative and rehabilitative therapeutic approaches for SCI/D. The VA Gordon Mansfield Spinal Cord Injury Consortium (VA-GMSCIC) is an effort to develop late-stage translational therapeutics in a nonhuman primate (NHP) model in preparation for clinical testing of emerging therapies. Prior and current funding has focused on multifaceted data collection, with multiple centers collaboratively collecting data on the same subject, each with specific domain of expertise. The current VA Merit Award built a Federated Data Commons to optimize decision-support, and knowledge- discovery across all data from VA-GMSCIC rehabilitation and regeneration studies. The renewal will integrate translational Electronic Health Records (tEHR), robotic rehabilitation, neuromodulation and machine intelligence tools to support advanced safety/efficacy studies.